Short Term Research Training Grant for Medical Students

Project Summary/Abstract
The proposed T35 program will provide financial support for up to 24 medical students from the NYU School
of Medicine (NYUSOM), as well as outside medical schools, to spend 9 weeks during the first summer of
medical school working on NIDDK-related research. In the current funding period, our T35 program has
steadily grown and attracted committed and passionate students to research. For example, in 2018, 26
students applied to the program and were accepted; of which 24 participated and 2 declined. Since 2003,
approximately 40% of students participating in the T35 Program pursued additional high quality research
opportunities that included a research year, graduating with research Honors or gaining entrance to our highly
competitive MSTP program. The core operational objectives of this renewal application are to: (1) provide
students with a pre-selected list of excellent mentors and projects, (2) create a selection process to identify
highly qualified students and optimize the probability that their work will lead to publication, (3) create
cohesion among the trainees and the participating mentors, (4) acquire data that can be used to judge the
success of the program and to implement changes to make it more successful. To accomplish these
objectives an internal advisory board (IAB) will advise the Program Director (PD) on selection of mentors,
projects and students. An external advisory board (EAB) will review the program each year and make
suggestions that assure it meets our core objectives. Each year the IAB and PD will select experienced and
successful mentors and solicit from them NIDDK-related projects to be offered to students. Selected
mentors must have an excellent mentoring record and be doing work relevant to the NIDDK mission.
Mentors will interview applicants and select a student for each project. With the mentor’s guidance, selected
students will write a proposal to submit to the PD and program staff for final approval. To further enhance
the probability that selected projects will lead to publication, students will submit an updated research plan
just prior to starting their summer project. Cohesion among the trainees and mentors will be created through
weekly meetings of students and faculty. Selected faculty will discuss their research and careers and, at
subsequent meetings, students will present either journal articles or work-in-progress seminars. At the
conclusion of their summer project students will be queried about their plans for publication and will be
asked to submit an abstract for the annual fall research day to be held at the NYUSOM. To track the success
of the program, students and mentors will be queried at the end of the summer regarding progress in the
key research competencies and students will be asked to comment on their plans for further research and
academic careers. Follow up questionnaires will be sent to students at the end of the clerkship year, at
graduation, and post- graduation with the intent to track their publication record, research plans, and their
evolving impression of the T35’s influence on their professional careers.

Public health relevance
Project Narrative The purpose of the proposed NYU NIDDK T35 Medical Student Training Program is to provide first-year medical students with an intense and rigorous exposure to biomedical research in areas relevant to the mission of the NIDDK in a program structured to provide practical support and foster excitement about research.